Oxidative stress-induced vascular pathology and dysfunction in Alzheimer’s disease

PROJECT SUMMARY/ ABSTRACT
Vascular contributions to cognitive impairment and dementia (VCID) is highly comorbid with Alzheimer's
disease (AD) where it exacerbates and hastens functional deficits. Mechanistic studies of vascular pathology
formation and its effects on brain function, especially in AD, is limited. Developing translational imaging for
application to mixed pathology models is necessary to understand the complex pathophysiological processes
that link VCID and AD. Recently, we modified and optimized the oxidative stress-induced photothrombosis
protocol (I.e. photoactivation of IV-injected Rose Bengal dye) for targeting individual capillaries in rodents. The
major advantage of this novel vascular oxidative stress model is that vessel stalls, occlusion, and
microhemorrhage can be followed in single capillaries in living mice, in real time, using multiphoton imaging. In
this R21, we aim to apply this technique to 5xFAD mice to generate and characterize a novel AD/VCID mouse
model en route to determining fibronectin— a matrix protein that supports vascular structure and integrity—as
an indicator for the oxidative stress that arises from both cerebrovascular disease and AD. Our ongoing work
on postmortem human brain specimens has revealed that astrocyte-derived fibronectin strongly colocalizes
with the oxidative stress marker, nitrotyrosine (NT) especially around cerebrovessels and Aβ deposits.
Photothrombosis of small cerebral arterioles revealed accumulation of fibronectin/NT colocalization at
intravascular and nearby perivascular regions, similar to what we observe in human AD brain tissue. Here, we
propose to use cutting edge physiology approaches combined with human postmortem brain specimens from
our world class brain bank at the Sanders-Brown Center on Aging, to test the hypothesis that oxidative
stress—indicated by NT incorporation into fibronectin— exacerbates cerebrovascular and synaptic
dysfunction in the context of AD. In Aim 1, we will determine the effect of microvascular oxidative stress on
neurovascular function in WT and 5xFAD mice. Multiphoton imaging techniques will be used to apply and to
observe, in real-time, the development of microvascular pathologies including blood vessel stalls, vessel
occlusion (infarct), and microhemorrhage as well as their effects on neurovascular coupling. Mouse brain
tissues and postmortem samples from humans with confirmed vascular pathology and AD pathology will also
be used to assess fibronectin/NT interactions with blood vessels, and to cross-validate our novel
photothrombotic mouse model of mixed AD/VCID pathology. In Aim2, we will test the hypothesis that oxidative
stress-induced microvascular pathology in 5xFAD mice leads to the global exacerbation of cognition and
synaptic function in the context of AD-like pathology. The proposed studies will fill a critical knowledge gap
surrounding the convergence of pathologic sequelae in cerebrovascular disease and AD. Moreover,
establishment of a novel mouse model for mixed AD/VCID pathology will help inform new strategies for treating
individuals with both AD and vascular pathology.

Public health relevance
Project Narrative This research project will reveal a fundamental mechanism of how oxidative stress disrupts the smallest cerebrovessels and subsequently alters the vascular-related matrix protein, fibronectin, en route to impairing synaptic and cognitive function in the context of Alzheimer's disease. Furthermore, this study will provide a novel mixed Alzheimer/vascular translational mouse model for future studies.